Toxicological Profiling of Engineered Nanomaterials (ENMs) in the MPS (RES)

Project Abstract See Research Strategy section for Project Abstract.

Public health relevance
Project Narrative No change from parent award.